Online Yoga vs Acceptance and Commitment Therapy for Treating Chronic Musculoskeletal Pain

PROJECT SUMMARY/ABSTRACT
More than 50% of veterans in primary care report experiencing chronic pain. Chronic pain is treatment-
resistant, and medications often include the risk of addiction or overdose. In recognition of the scope of this
problem, the VA has encouraged the use of complementary and integrative health (CIH) in conjunction with
conventional pain treatments. Yoga is a popular CIH approach and is effective in treating many types of
chronic pain, including musculoskeletal pain which is the most common type. While all yoga is potentially
therapeutic, online delivery of yoga (“teleyoga”) has many advantages over in-person yoga; it can reach
individuals who lack access to healthcare due to geography, poor health, or other barriers. The use of
telehealth has become widespread, and the high utilization of yoga for treating chronic pain illustrates a need for
high quality evidence for the efficacy of teleyoga. However, no randomized clinical trial (RCT) has asked whether
teleyoga is an effective treatment for chronic musculoskeletal pain. To address this research gap, we recently
completed an NCCIH-funded R34 feasibility study of teleyoga for treating chronic musculoskeletal pain in
veterans. We showed that a synchronous teleyoga protocol delivered in real-time over Zoom to groups of
veterans was a feasible treatment and that it had promise for alleviating pain. We now propose a fully powered
RCT to evaluate the efficacy of teleyoga for chronic musculoskeletal pain. We argue the most impactful design
is to compare teleyoga to a standard pain treatment. We will use Acceptance and Commitment Therapy (ACT)
as a comparison group as it is the most robust nonpharmacological treatment available for musculoskeletal
pain, it is recommended by the VA and American Psychological Association and has demonstrated efficacy in
veteran populations. A noninferiority design will be used as appropriate for trials in which the primary objective
is to show a novel intervention (teleyoga) is clinically noninferior to a standard well-established treatment
(ACT). We will recruit and randomize 328 veterans with chronic musculoskeletal pain to one of two groups
(teleyoga, ACT; n=164 per group) and treatment will be delivered to groups of approximately 5 individuals
online over 8-weeks (ACT) or 12-weeks (teleyoga). Measures will be taken at baseline, end-of-treatment, and
6 months after treatment, and will include pain interference with daily activities (primary outcome), pain
severity, depression, sleep, and dropout. We expect pain interference will improve in both groups following
treatment, and that teleyoga will not be clinically inferior to ACT. Overall, this trial seeks to provide high-quality
evidence for the efficacy of teleyoga as a treatment for chronic musculoskeletal pain. The results will help
promote teleyoga as a scalable, accessible, and effective treatment.

Public health relevance
PROJECT NARRATIVE Chronic musculoskeletal pain is the most common health concern in primary care, and yoga has emerged as a popular and effective treatment. The use of telehealth has become widespread for the delivery of therapies, yet no clinical trial has asked if online yoga is an effective treatment for chronic musculoskeletal pain. We will address this question by comparing online yoga to a gold-standard treatment (online Acceptance and Commitment Therapy; ACT) using a noninferiority randomized clinical trial involving 328 veterans.